HHSN261201500003I; HHSN26100082; 400.001.0082.0001; NCI OD-Frederick; Appropriated; RI; 125218 Exterior Ladders - Phase 2 -Buildings 434, 550, 560, 567; 09/24/2018 06/23/2020

Appropriated; RI; 125218 Exterior Ladders - Phase 2 -Buildings 434, 550, 560, 567